Mental and Physical Health in Children of Latino Migrant Farm Workers: A Multi-Level Longitudinal Examination of Risk and Resilience Factors

Project Summary/Abstract is not required per supplement request to R01. This supplement will not change the
parent R01.

Public health relevance
Narrative The postdoctoral pathway is an important path toward a future academic career, but the numbers of postdocs trained in health disparities research (especially those who are underrepresented minoritized (URM) scholars) remains low across academic disciplines. The aim of this supplement is to recruit and develop a diverse cohort of postdocs to advance scholarship, practice, and knowledge of conducting research with underrepresented and marginalized populations. We will provide a holistic training environment that supports health disparities research, professional development, and addresses professional learning, DEIA, and mentoring.